Orally active CBP/p300 degraders

Abstract: The histone acetyltransferase CREB-binding protein (CBP) and its paralogue p300 protein are key
transcriptional co-activators and attractive therapeutic targets for human prostate cancer and other types of
human cancers. Development of highly potent and orally active small-molecule degraders of CBP and p300
proteins represents a promising new therapeutic strategy. Our preliminary data demonstrate that our designed
degraders are highly effective in inducing rapid and complete degradation of both CBP and p300 proteins in
tumor cells at sub-xnanomolar concentrations and >100-times more potent in in inhibition of cell growth than
CBP/p300 inhibitors. Our optimized CBP/p300 degraders achieve excellent pharmacokinetics and oral
bioavailability in mice. Oral administration of our optimized CBP/p300 degrader strongly inhibits tumor growth
in animal models of human cancer at well-tolerated dose-schedules. Collectively, our preliminary data provide
compelling data to support the further evaluation, optimization and development of orally active CBP/p300
degraders as a new anticancer therapy.

Public health relevance
Narrative: Despite the major advancement in the development of new therapies for the treatment of human prostate cancer, prostate cancer remains the second leading cancer cause of death in north American men. Therefore, there is an urgent need to develop new and more effective therapies for the treatment of human prostate cancer, particularly metastatic, castration-resistant prostate cancer. In this R01 award, we propose to develop orally active CBP/p300 degraders as a new class of therapy for the treatment of advanced, human prostate cancer.